Clinical Neuroscience Research Training Program in Psychiatry

SUMMARY
This training program, now in its 27th year, is designed to meet the urgent national priority of increasing the
number of highly trained psychiatric physician-scientists conducting clinical and translational patient-oriented
research in mental health. In order to be effective independent investigators, psychiatric physician-scientists
must be fully trained in both clinical neuroscience and modern clinical-translational research methodologies.
The ever-increasing complexity of the science and methods requires that individuals receive specialized
training in order to take full advantage of the rapid advances occurring in the field. This 2-3 year program will
utilize a curriculum designed to give trainees mastery of the fundamentals of molecular and cellular
neurobiology, neuropharmacology, neuroimaging, psychiatric genetics, computational methods, and the
responsible conduct of research in human subjects. Trainees will benefit from individualized mentorship by
members of a large and multidisciplinary group of research training faculty within the Department of Psychiatry.
The rich training environment is supported by robustly funded research programs and infrastructure within
and associated with the Department of Psychiatry. These include: 1) the Clinical Neuroscience Research Unit,
2) the National Center Post-Traumatic Stress Disorder, 3) the Center for the Translational Neuroscience of
Alcoholism, 4) the Yale Stress Center, 5) the VA-Connecticut research community and the Neurobiological
Studies Unit, 6) the Wu-Tsai Institute for the study of human cognition; 7) the Yale PET Center, 8) the
Magnetic Resonance Research Center, 9) the Program in Human Psychiatric Genetics, 10) the Interventional
Psychiatry Service, 11) the Division of Neurocognition, Neurocomputation, and Neurogenetics, 12) the Yale
Program for Psychedelic Science, and others. Trainees will conduct research in specialized inpatient and
outpatient research facilities and specialty clinics, in collaboration with basic, translational, and clinical research
resources within and beyond the department. They also form a large cohort of research trainees, providing
community and mutual support as they navigate the challenging transition to independent careers as
physician-scientists.
The Yale Department of Psychiatry has an exceptional training record of producing nationally and
internationally prominent physician-scientist researchers in psychiatry over six decades. The renewal of this
highly successful T32 training program will allow us to continue our highly impactful work, increasing the
number of superbly trained patient-oriented physician-scientist research psychiatrists entering the national
workforce, and thereby driving the pace of innovation that our field so badly needs.

Public health relevance
NARRATIVE Mental illness affects approximately 15% of the population, creates enormous disability and cost, and has been stubbornly persistent over the decades. To fundamentally alter this trajectory we must recruit and train the next generation of physician-scientist researchers who will generate the advances in diagnosis, treatment, prevention, and cure that we need to alleviate this burden. Yale’s T32-funded Clinical Neuroscience Research Training Program, of which this is a renewal application, has an exceptional track record of training psychiatric physician-scientists, which we here aim to continue and enhance.